FEBio - Finite Elements for Biomechanics and Biophysics

SUMMARY Finite element analysis has become an indispensable tool for research and discovery in the biomedical sciences. Historically, the lack of an open software environment that was tailored to the needs of the field hampered research progress, dissemination of research and sharing of models and results. To address these issues, we developed the FEBio software, a FE framework designed specifically for analysis in biomechanics and biophysics. FEBio employs mixture theory to account for the multi-constituent nature of biological tissues and fluids, unifying the classical fields of irreversible thermodynamics, solid mechanics, fluid mechanics, mass transport, chemical reactions and electrokinetics. In addition, we developed an integrated development environment, called FEBio Studio, which offers a graphical user interface for building, running, and analyzing FEBio models. In this administrative supplement application, we propose two aims: 1) Improve the sustainability and reusability of FEBio and FEBio Studio; 2) Adapt the FEBio solver to facilitate cloud computing. These new capabilities will expand the use of best software practices in the development of FEBio and FEBio Studio, and improve the accessibility of cloud computing with FEBio, facilitating scientific advancement.

Public health relevance
PROJECT NARRATIVE This project will improve the sustainability and reusability of the FEBio and FEBio Studio software packages, which are used for computer simulations in the fields of biomechanics and biophysics. These software packages already support over 13,000 users in their research. The aims of the administrative supplement will expand the utility and of FEBio and thus increase its use for scientific discovery and innovation by biomedical scientists.